Gadgetron Global Network and Artificial Intelligence Powered Cardiac Imaging

Past year saw new development in AI applications and data curation. Following applications had been developed and deployed to clinical scanners:
. Cardiac perfusion mapping with AI based segmentation and reporting
. Cardiac cine imaging with AI based contouring, for retro-gated and free-breathing imaging
. AI based landmarking
. AI based measurement and reporting of global longitudinal shortening (GLS)
. AI MR denoising
. AI based segmentation and reporting of myocardial T1 and T2
. Cardiac function quantification and reporting from cine imaging using AI